Alexithymia Intervention for Suicide (ALEXIS)

Project Summary:
Suicide rates among veterans with Serious Mental Illness (SMI) are intractably high. Yet, at present available
treatments offer only minimal to limited benefits to ameliorate this risk, despite a VA-wide implementation of
enriched suicide prevention services and the availability of a national suicide hotline. This dire state represents
a serious public health concern and a critical target for interventions. In response to this state, the
Rehabilitation Research & Development Service (RR&D)’s Behavioral Health & Social Reintegration Program
has highlighted the need for development of suicide prevention interventions that enhance social reintegration,
functional outcomes, and improve overall participation in society. Germane to Social Functioning (SF),
extensive evidence from basic affective neuroscience research indicates that effective SF requires intact
emotion awareness. Speciﬁcally, emotions are posited to provide crucial information about the signiﬁcance of
social situations and help to guide potential actions to be taken to navigate such situations. Negative emotional
experiences in particular have critical informational value in signaling the need to adjust one’s current state or
activity. As different emotions may call for the use of distinct response strategies, lack of or reduced awareness
of experienced feelings may make it difﬁcult for individuals to choose response strategies for dealing effectively
with social situations, resulting in poor SF. Consistent with these findings, recent reports indicate alexithymia, a
transdiagnostic clinical syndrome characterized by poor emotion awareness, to be highly prevalent among
veteran and civilians with SMI populations, with a recent large systematic review and meta-analysis indicating
alexithymia predicting suicide ideation and behavior (with large and small effect sizes, respectively). Relatedly,
previous reports indicate alexithymia has a detrimental impact on treatment outcomes. Altogether, these
findings suggest alexithymia may play a key role in impacting suicide risk and treatment response in veterans.
Yet, despite its pervasiveness, chronic presentation, link to SMI and poor SF, and impact on clinical outcomes,
the putative impact of alexithymia on suicide risk has not been investigated in veterans with SMI at risk of
suicide. Building on these findings, the goal of this project is to test the feasibility and acceptability of a novel,
blended psychoeducation and digital mHealth (mobile health) intervention designed to target alexithymia and
poor SF to reduce suicide risk in veterans with SMI. Employing a proof-of-concept design, 40 participants will
attend weekly group psychoeducation sessions targeting emotion awareness and SF along with an innovative
mHealth emotion awareness skill training via smartphone to reduce alexithymia, enhance SF, and reduce
suicide risk. Results from the present study will provide comprehensive characterization of suicide risk among
veterans with SMI, provide preliminary acceptability and feasibility data, and will inform the development of a
randomized clinical trial to test the efficacy of the intervention to ameliorate suicide risk in this population.

Public health relevance
Project Narrative: Suicide rates among veterans with Serious Mental Illness (SMI) are intractably high, representing a serious public health concern and a critical target for interventions. Yet, at present available treatments offer only limited benefits. Thus, there remains an urgent need to identify novel approaches to address suicide risk in this population. Previous reports have linked suicide risk with poor social functioning (SF). Emerging evidence from basic affective neuroscience research has indicated effective SF is contingent on intact emotion awareness. Consistent with these findings, individuals with SMI at risk of suicide display SF difficulties along with poor emotion awareness (i.e., alexithymia). Employing a proof-of-concept design, the aim of the present study is to test the feasibility and acceptability of a novel, blended psychoeducation and digital mHealth intervention with smartphones designed to target alexithymia and poor SF to reduce suicide risk in veterans with SMI.